Structural Analysis and Inhibitor Optimization of Cryptosporidium n-myristoyltransferase for Drug Discovery

ABSTRACT
Each year over 525,000 children under age five are killed by diarrhea caused by infectious disease.
Cryptosporidiosis, the second most frequent cause of childhood diarrhea, is an infection caused by
colonization of the intestines by the eukaryotic parasites, Cryptosporidium parvum or C. hominis, and
particularly damages and kills malnourished children. In contrast to other Apicomplexans (such as Plasmodium
or Toxoplasma), there is no required insect vector or animal host, since parasites can be transferred directly
from human to human through the fecal-oral route. Despite the high incidence and significant impact on
malnourished children, there are no effective treatments for cryptosporidiosis.
We had previously screened the GSK Tres Cantos proprietary library of ~2 million compounds against
P. falciparum N-myristoyltransferase (NMT). NMT is an enzyme which transfers myristate, a 14-carbon fatty
acid, to the N-terminal glycine residue of proteins co-translationally, which contributes to targeting the substrate
protein to membrane regions. NMT has been validated as a drug target in fungal and parasitic diseases,
including malaria and leishmaniasis. We hypothesized that NMT high-throughput screening (HTS) hits effective
against Plasmodium would also be active against Cryptosporidium and tested the top eight hits against
Cryptosporidium parvum NMT (CpNMT). Of those top eight hits, three were effective against the purified
enzyme and one showed activity against the parasite in vitro. A follow-on synthetic chemistry and structure-
based drug design program further developed these hits into a lead series (called Series-2) of highly effective
(~10nM IC50) inhibitors with 500-1000 X selectivity over the human enzyme. The two most promising leads
from the Series-2 scaffold were then tested in a mouse model of infection and found that both molecules
completely cleared infection. These data serve to chemically validate NMT as a druggable target for the
treatment of Cryptosporidiosis. In this proposal we intend to further develop lead compounds in order to
improve drug-like characteristics in preparation for preclinical drug development.

Public health relevance
PROJECT NARRATIVE The investigators have identified a new lead series of compounds that are effective at curing mice of a parasitic infection. The project will conduct lead optimization and characterization studies using in vitro and in vivo assays. Synthetic chemistry will be guided by structure-based rational design and final compounds will be tested in an animal model.